Scientific Information Management and Literature-Based Evaluations for the NTP - Support for External Peer Review

A number of complex scientific reports are prepared under this contract on the Report Development project. Coordination of peer review includes managing a directory of scientific experts, conflict of interest screening for reviewers and companies with potential financial interest, and compiling documents for internal DNTP record keeping. Peer reviews conducted under this project included Systematic Reviews on Fluoride and CLARITY bisphenol A, Technical Report on sodium tungstate dihydrate, Technical Reports on phthalates (DEHP, dibutyl phthalate), Toxicity Reports on Aspergillus fumigatus, resveratrol, ionic liquids, usnic acid, and usnea lichens, and Developmental and Reproductive Reports on 24HMBP, EHMC, Bisphenol AF, and MPEP. Keywords: peer review